Astrocyte regulation of cortical neurodegeneration in C9orf72 FTD/ALS

PROJECT ABSTRACT
The GGGGCC (G4C2) hexanucleotide repeat expansion (HRE) in the first intron of the gene C9orf72, is
the most common genetic abnormality associated with frontotemporal dementia (FTD) and amyotrophic lateral
sclerosis (ALS). The disease pathogenesis ultimately leads to the concurrent degeneration of cortical forebrain
and spinal motor neurons, and result in the clinical deficits of motor function and dementia. While the C9orf72-
FTD/ALS disease pathogenesis has been well characterized in spinal motor neurons and a contribution of the
observed neurodegeneration has been attributed to spinal cord astrocytes, there is little known about the
pathobiology in cortical astrocytes and their role in cortical neurodegeneration, which is proposed to contribute
to the dementia symptoms in this patient population. In the parent grant of this supplement, we hypothesized
that cortical astrocytes play an integral role in the non-cell autonomous disease pathology contributing
to the degeneration of cortical neurons in C9orf72-FTD/ALS. To test this hypothesis, we proposed cellular
and molecular analyses of postmortem forebrain autopsy tissues and patient-derived iPSC cortical neurons and
cortical astrocytes co-culture systems. With this supplement, we expand on these studies and propose to
examine the contribution of astrocyte-neuron contact-dependent mechanisms (Aim 1) and astrocyte-secreted
factors (Aim 2) in cortical neurodegeneration. These contributions will be tested using iPSC cortical astrocyte-
cortical neuron co-culture models. The graduate student assigned to this project, Ms. Lynette Bustos, will focus
on known astrocyte proteins (e.g., neuroligins and ephrins) that make direct contact with neuronal synaptic
proteins, as well as astrocyte secreted proteins implicated in synapse structure and function (e.g. Hevin, SPARC,
thrombospondins, glypicans). Lynette will thoroughly examine the role of these proteins in the degeneration of
cortical neurons. Together with the studies performed under the parent grant, these analyses will for the first
time elucidate the contributing role of cortical astrocytes in the neurodegeneration of cortical neurons in C9orf72-
FTD/ALS, addressing the disease mechanisms of dementia in this spectrum disorder. Additionally, this work will
provide novel opportunities for drug target identification with the hope of identifying novel therapeutics for the
affected patient populations.

Public health relevance
PROJECT NARRATIVE In C9orf72 frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS) the disease mechanisms cause concurrent degeneration of forebrain cortical neurons and spinal and cortical motor neurons, resulting in clinical deficits in cognitive and motor functions. In ALS, a contribution of the observed spinal motor neurodegeneration has been attributed to spinal cord astrocytes, but little is known about the role of cortical astrocytes and its regulation of cortical forebrain neurons. This supplemental research proposal will determine if aberrant direct astrocyte-neuron interactions and/or secretion of astrocytic factors contribute to the neurodegeneration observed in the forebrain of ALS patients with FTD dementia symptoms.